The roles of midbody associated mRNAs in regulating cell proliferation and differentiation

Project Summary
This Project Summary/Abstract was originally submitted with R01 GM143774 and is included here unchanged
to satisfy submission system requirements.
During mitosis, the mother cell divides by the formation of a cleavage furrow, leaving two daughter cells
connected by a thin intercellular bridge. The resolution of this bridge, abscission, leads to the separation of the
two daughter cells. During ingression of the cleavage furrow, the central spindle microtubules are compacted
to form a structure known as the midbody (MB). It is now well established that MB regulates cytokinesis by
recruiting abscission-mediating proteins, such as ESCRT complex, as well as several regulators of abscission
checkpoint. Until recently, the MB was thought to be discarded after division by releasing it into extracellular
space. However, recently it was shown that MBs accumulate in stem and cancer cells after mitosis has been
completed (called MBsomes) and it has been proposed that MBsomes function as novel signalling platforms
that regulate cell differentiation and proliferation. Recently we developed a protocol for purification of post-
mitotic MBs and completed their proteomic and RNAseq analyses that led to identification of several mRNAs
and mRNA-binding proteins that accumulate at the MB. Importantly, MB-enriched mRNAs encode several
ESCRT complex subunits, as well as proteins that stimulate cell proliferation. Furthermore, we show that these
MB-enriched mRNAs can be transferred to the neighboring cells via post-mitotic MB internalization. Based on
all of these findings, we hypothesize that targeting of selected mRNAs to the MB during cytokinesis play
a key role in regulating cell abcission and post-mitotic MBsome signaling. Here we propose three
specific aims to test this hypothesis. First, we will map and characterize the domain(s) within 3'-UTR that are
needed for mRNA targeting during cytokinesis. We will then use candidate approach, as well as proteomic and
CRISPR screens, to identify RNA-binding proteins that interact with these 3”-UTR domains and regulate
mRNA targeting and localized translation at the MB. Second, we will test the possibility that MB
accumulation/translation of ESCRT mRNAs mediates ESCRP complex targeting to the MB. Third, we will test
whether MBsome-dependent transfer of specific mRNAs, such as mRNA encoding proliferation regulator
CENP-E contribute to MBsome-induced cell proliferation.

Public health relevance
Project Narrative This Project Narrative was originally submitted with R01 GM143774 and is included here unchanged to satisfy submission system requirements. The goal of this project is to understand the roles of post-abscission midbodies (MBs). We already have shown that these MBs are internalized by neighboring cells where they form a novel signaling organelles known as MBsomes. Importantly, it was suggested that the accumulation of intra-cellular MBsomes regulates cell proliferation and differentiation. Thus, completion of this project will identify and characterize the molecular machinery governing the internalization and formation of MBsomes, as well as will define signaling pathways that mediate MBsome function.